Characterizing adherence and estimating per-protocol effects for pediatric dolutegravir use

PROJECT SUMMARY
Continued access and adherence to antiretroviral therapy (ART) is crucial for pediatric populations
living with HIV to prevent AIDS-related comorbidities. However, there are several unique challenges to
treatment adherence in pediatric populations, including caregiver factors, and medication palatability and
tolerability. Little work has been done in characterizing patterns and factors related to the timing of ART
nonadherence since initiation of therapy in children. Additionally, new ART formulations available for adults
have been slower to obtain approval for use in pediatric populations due to difficulty in assessing efficacy in
trials. Bringing modern causal inference methods to the analyses of pediatric trials through rigorous
estimation of per-protocol effects can help overcome some of these difficulties, and help bring
analyses of pediatric trials into the modern age.
The objectives of the proposal are to (1) characterize the barriers to pediatric dolutegravir
combination therapy adherence, and (2) estimate per-protocol effects of treatment failure by 96 weeks
in the pediatric HIV trial, taking into consideration the unique barriers to medication adherence in
pediatric populations. Data from the ODYSSEY trial, a phase II/II open-label non-inferiority trial assessing
dolutegravir-based ART compared to standard of care in an international sample of children aged 2 to 18, will
be used to characterize baseline and time varying factors influencing time to protocol deviation, and then
estimate per-protocol effects impacting 96-week treatment failure correcting for such protocol deviations
through implementation of modern causal inference methods and machine learning.
The completion of the proposed aims will provide evidence on characteristics contributing to timing of
protocol deviation and estimates of per-protocol effects of treatment failure by 96 weeks corrected for such
protocol deviations in the ODYSSEY trial for first or second line dolutegravir use compared to standard of care
in a pediatric population. These results will (1) provide substantial information on factors related to
timing of eventual ART nonadherence so that appropriate clinical intervention can be developed to
prevent nonadherence related to these factors, and (2) provide an example of modern per-protocol
analyses in pediatric trials which will serve as guidelines for future per-protocol analyses in pediatric
trials. The training plan outlined in this F30 proposal will provide the applicant with necessary skills in modern
causal inference methods and clinical medicine to become a productive and successful physician scientist at
the intersection of pediatrics and application of modern causal inference methods for pediatric trials.

Public health relevance
PROJECT NARRATIVE Adherence to antiretroviral therapy is vital for prevention of AIDS-related deaths and comorbidities in children living with HIV, but pediatric populations face greater challenges to adherence compared to adults including difficulties with medication tolerability. Pediatric trials and evidence generated from these trials have lagged behind adult trials, especially in regard to use of modern causal inference methods to address analytic challenges. This proposal will use data from a pediatric randomized trial of dolutegravir-based ART compared to standard of care and novel epidemiologic methods to demonstrate how to improve evaluation of evidence generated from pediatric trials.